Al-Supported In-Home Brain Assessments for Older Adults and Persons with Alzheimer's Disease

Project Summary
More than 5 million Americans are living with AD—the sixth leading cause of death in
the U.S. and the only leading cause of death that cannot be prevented, cured, or
substantially slowed. Early and accurate diagnosis can save up to $7.9 trillion in medical
and care costs and is therefore a critical need. However, going to the hospital for health
evaluations can be onerous for everyone, particularly so for older adults with limited
mobility, vision and/or cognition, as well as variable access to transportation and home
caregivers. Home-based assessment could be a solution, but existing assessment tools
for AD—including PET, MRI, and biomarkers in cerebrospinal fluid or plasma—are
cumbersome, expensive, or invasive, making them ill-suited for home use or even
regular screening purposes. An easy-to-use, home-based screening test with good
sensitivity and specificity for identifying AD would thus be of tremendous value and fill
an unmet clinical need. No such technology currently exists.
Over the past 15 years, our group has been developing battery-powered wearable
neurovascular and physiological monitoring technologies to facilitate applications
ranging from seamless perioperative monitoring to brain assessment in spaceflight.
These devices have the potential to act as a ‘mobile clinic’ to support brain-based
assessments at home, and have been utilized in numerous remote and self-deployed
settings. They have not, however, been assessed for their feasibility for use by older
adults, AD patients.
In this project, we propose to achieve the following specific aims. Aim 1: Generate an
adapted version of NINscan so older adults or AD patients can collect high quality brain
and physiological data at home. Aim 2: Generate and share a database from home data
collections during rest and cognitive tasks in older adults and AD patients recruited from
the MassAITC-affiliated MADRC Core. Aim 3: Use transformer- based artificial
intelligence (AI) models to (i) identify individuals with suspected AD, (ii) predict cognitive
testing scores, and (iii) predict plasma tau levels, all using the neural and vascular
biomarkers collected during self- (or caregiver-) deployed recordings at home. The
results of this project will help make brain-focused AD-relevant testing easier for both
patients and clinicians, and could potentially suggest a more cost-effective and
sustainable future health care model for AD.

Public health relevance
Project Narrative Alzheimer’s Disease (AD) is a growing burden, but current medical management relies on trips to the clinic and expensive/burdensome procedures. Recent research has demonstrated that cerebrovascular changes occur early in AD. We propose to investigate the feasibility of developing a brain assessment tool for aging and AD that is suitable for use at home and is based on (1) an easy-to-use, self-deployable technology and (2) machine learning to provide reliable AD brain assessments.